Research Project: Community Engagement Core

PROJECT SUMMARY/ABSTRACT – Community Engagement (CE) Core
The Community Engagement (CE) Core advances the scientific mission of CAPS by closing
the gap between research and practice. Engaging the community in research to address
policies, practices, and programs relevant to their well-being is critical to ending the HIV
epidemic and ensuring that the full prevention and care toolbox is accessible to all. CAPS will
base its CE activities on substantial theory and evidence, guided by the UK National Institute
for Health and Clinical Excellence (NICE) Community Engagement framework, to promote
the mutual and bidirectional exchange of information, ideas, and expertise between
community members and researchers. The Core proposes to carry out three aims: (1)
Connect high-impact HIV science to communities (scientist à community); (2) Integrate
community perspectives into high-impact HIV science (community àscientist); and (3) Foster
community-engaged research (communityßà scientist). The CE Core will increase community
access, both domestic and international, to CAPS's innovative HIV research by implementing
evidence-based translation strategies, by reviewing, synthesizing, translating, and broadly
disseminating cross-cutting HIV research findings. The CE Core will also support the CAPS
Community Advisory Board to provide community input to strengthen the design,
implementation, and dissemination of research findings, especially considering the co-
occurring and multiplicative factors that underlie HIV health disparities and by including those
working in traditional and nontraditional HIV-related health systems. And the CE Core will
strengthen the capacity of CAPS scientists and community stakeholders to participate
collaboratively in CE research on HIV, including research on co-occurring and multiplicative
factors resulting in HIV health disparities, and research on health systems. Through its
activities, the CE Core will help CAPS scientists thoughtfully engage with communities to
formulate and conduct research projects, interpret and disseminate the findings, and foster
research that is prioritized by, meaningful to, and respectful of people affected by HIV.